AII EFFECTS ON PAI/TPA--SCORE HYPERTENSION GENETICS PROTOCOL 2

The purpose of this study is to evaluate the interactions between the hormones which regulate blood pressure and the body's blood clotting system.